A Mobile Informatics Solution to Assist Caregivers with Care Coordination and Social Engagement

Abstract
In this phase 2b SBIR, we aim to support caregivers of Persons with Memory Concerns (PWMC) through
development of an informatics system to both increase PWMC social engagement and promote care
coordination. Based on positive response from our completed phase 2 project, the new phase 2b will deploy an
augmented version of our Social Reminder System app technology, adding new features suggested by
participants in our phase 2 randomized control trial and qualitative interviews with users. The new Social
Reminder System will focus on decreasing caregiver stress and care burden with features to make the system
more mobile and allow for remote monitoring of PWMC by caregivers. More than a third of older adults - and
more than 25% of older adults with memory concerns - do not live with their care provider. There are more
than 14 million older adults that may be at an increased risk of social isolation and when coupled with memory
concerns, may face potentially hazardous safety risks. Even co-resident care providers who work or spend
time away from home may face elevated risk due to episodic absences and having to share care
responsibilities with a broad network of friends and family. These issues have been shown to lead to elevated
care burden, elevated stress levels for care providers, and premature nursing home placement. Tech-enabled
reminder systems can increase social interaction and promote care coordination, but often face barriers to
uptake due to older adults’ documented reservations with technology engagement. Our next-generation social
reminder system will run on a tablet computer and is designed to promote social engagement and ease
caregiver burden for care providers. Modifications are designed to enhance (1) uptake and ease-of-use by
older adult’s care providers and PWMC, (2) tools to promote social engagement for PWMC, (3) remote
monitoring, and (4) care coordination care by care providers. Ease-of-use: Tablets will automatically connect to
caregiver approved trusted circle members’ cell phones. Social connection: reminders will now include both
social and care support service visitors. The new system will also provide a two-phase reminder system: one
before the visit and a separate reminder during the visit. The system will also allow trusted circle members to
record a standing message that plays prior to arrival (e.g., for standing appointments and care services), or a
one-time message stating the name of the visitor and the purpose of the visit. Care coordination: the system
will designate a care provider who will receive notifications for any cell phones with the free app that comes
within range of the PWMC’s tablet. This will allow caregivers to monitor all visitors to PWMCs (social,
scheduled care, and medical services). We further include a feature that allows visitors to set reminders for
caregivers for (1) upcoming visits, (2) upcoming medical appointments, or (3) any notes from medical visits.
Location information will now be a part of the system. The caregiver will be able to use their care coordination
app to monitor if the PWMC has been taken to an appointment. Remote monitoring: To enhance security, the
system will retain a log of all visitors - which will allow tracking any package deliveries or solicitations - and will
retain a log of all visitors.

Public health relevance
Project Narrative In the United States, two-thirds of the 5.4 million people with memory concern (PWMC) live in their homes in the community, reflecting the growing desire of Americans to age in place. The complexity of needs of PWMC including medical, behavioral, and social needs, make it one of the most expensive chronic conditions in the United States, and a strong candidate for improving care through care management support. Navigating fragmented systems of health care, long-term services and supports, and community or social supports to meet the diverse needs of PWMC is challenging. Currently, family, and unpaid caregivers provide the bulk of support PWMC receive to continue living in their homes. Caregiver burden, measured objectively (count of hours) or subjectively (caregiver’s perception of impact on themselves), is associated with poorer outcomes among people living with dementia. Given most PWMC live in their homes, people are concentrating on the home setting as an effective way to identify and address a broader set of unmet needs (e.g., social, and environmental determinants of health) and provide more comprehensive “family-centered” support. This approach aligns with value-based care principles and bridges the health care with community setting.